Validating a data science methodology for patterns of mental health services use: The patient record of clinical experience sequence study (PROCESS)

Background: An effective learning healthcare system needs measures that help managers
identify how to promote system-level improvements. One opportunity to influence system level
improvements is to directly measure the care sequences provided to patients that may reflect
decreased efficiency and increased care fragmentation. We propose to determine whether a VA
administrative data can be used to construct reliable measures of care sequences.
Significance/Impact: Our innovation is in adapting a data science sequence analysis
methodology to VA administrative records. This methodology has the potential to highlight care
fragmentation and integration. Fragmentation is arguably the most important underemphasized
goal in VA. Performance goals exist for quality of care and access, and there is a strong
infrastructure for managing cost. However, there is limited focus on reducing fragmentation and
improving integration, in part due to the lack of adequate measures. VA priorities include more
efficient resource use. Two VHA strategies to increase efficiency are to diligently find areas of
waste and correct to generate savings, and to improve the delivery of health care services by
ensuring care coordination across all care settings. Sequence-based fragmentation and
integration measures have the potential to directly inform these strategies.
Specific Aim: The specific aim of this two-year proposal is to determine whether VA
administrative data can be used to reliably measure mental health sequences of care. As an
exploratory aim, we will determine whether sequences may represent care fragmentation.
Methodology: We will use the VA Corporate Data Warehouse to collect evidence for internal
consistency and test-retest reliability. Approximately 46,000 Veterans will be sampled in each of
6 annual cohorts (FY2013-FY2018) across 54 medical centers. We will use sequence analysis
to identify clusters of similar sequences that are characterized by a common consensus
sequential pattern. Internal consistency will be determined by comparing random patient
samples to determine if patient sequences are more similar within consensus sequential
patterns than between patterns. Test-retest reliability will compare patterns over time. We
expect a step function where sequences will be similar over time, with periodic changes as
capabilities improve. Generally, proximal sequences will be more similar than distal sequences.
For the exploratory aim, we will calculate patient-level correlations with administrative database
measures of care fragmentation and facility-level correlations with VA performance measures.
A Delphi process with an expert panel will the degree to which each sequence generated by the
methodology may measure fragmentation. This will provide preliminary data for the next study.
Next Steps/Implementation: This two-year study will determine whether the sequence analysis
method can be applied to VA administrative data to identify reliable care sequences. The output
of the Delphi process and the convergent and discriminant validity tests will allow the team to
develop specific hypotheses about VA depression care sequences that will be tested in a follow-
up study. The next step will be to determine the association of depression care sequences with
mental health symptoms, functioning, satisfaction, and cost. Our long-term goal is to develop a
method for measuring care sequences in near-real time and provide feedback to managers and
clinicians to identify patients regarding care sequences that may require intervention.

Public health relevance
VA has been aggressively hiring additional staff to improve mental health access and working to improve productivity, but productivity measures do not reveal what sequences of care might affect capacity. We propose to use a data science method, sequence analysis, to determine whether we can use VA administrative data to measure reliable sequences of mental health care. We focus on sequences of mental health services following a new diagnosis of depression because depression is highly prevalent, and a new diagnosis is likely to initiate a new sequence of care. Our long-term objective is to implement sequence analysis measures to help managers and clinicians identify whether patients are engaged in a sequence of care that is associated with positive or negative outcomes.